Administrative Core

Summary: Administrative Core personnel, including the Director, Associate Director, and three staff (Administrative Program Manager, Technical Manager and Assistant Technical Manager), will oversee and coordinate the scientific and administrative operations of the Center's activities and foster interactions and synergism among Center research projects and scientific cores with the ultimate goal of ensuring that the Center meets the annual milestones established in collaboration with NIH CounterACT program officer(s). Additionally, the Administrative Core will coordinate interactions with the NIH CounterACT administration, our External Advisory Board and the general CounterACT research community. The specific aims of the Administrative Core encompass five areas of administrative responsibility: Aim 1: Develop a strategic plan for achieving annual Center and project milestones and ensure its effective and efficient implementation. Aim 2: Provide scientific leadership and logistical support to coordinate and integrate Center activities and promote interactions among Center investigators. Aim 3: Facilitate data and resource sharing among Center investigators and other CounterACT investigators. Aim 4: Provide budgetary oversight and grants management. Aim 5: Ensure the safety and security of personnel, materials, data and facilities.